Neural dynamics of speech encoding and maintenance during phonological working memory

PROJECT SUMMARY
Phonological working memory is the capacity to maintain and manipulate representations of speech
sounds temporarily in working memory. It is believed to play a critical role in many aspects of language
development, such as vocabulary learning, sentence processing, and acquisition of literacy skills, and deficits
of phonological working memory are diagnostic of many developmental language disorders. The classic
theoretical framework for phonological working memory posits that information is held in a dedicated working
memory storage buffer, separate from speech perception cortex; although more recent cognitive models favor
a view in which the same cortical substrate responsible for perception of phonological information also
supports maintenance of those neural representations during working memory delay. Indeed, recent human
neuroimaging studies show phonological working memory load-dependent recruitment of speech-perception
cortex during a variety of tasks and in particular, activation in left superior temporal gyrus has been shown to
correlate with out-of-scanner performance on clinical assessments of phonological working memory. However,
because these studies are not able to temporally distinguish activation during phonological encoding from
persistent maintenance of phonological representations after encoding, we do not know which of these
processes to attribute to the observed correlations with behavior. Therefore, the theoretical implications of
these findings, as well as their clinical interpretations, critically depend on resolving phonological encoding and
working memory maintenance processes in time and space. We propose to investigate the neural dynamics of
phonological working memory using intracranial electrocorticography, which allows for the simultaneous
recording of many discrete neural populations with millimeter- and millisecond-resolution by placing electrodes
directly on the cortical surface of the brains of awake, behaving human patients undergoing surgery for
medically intractable epilepsy. This technique will allow us to observe directly the relationship between speech
encoding and maintenance during phonological working memory. Through three specific aims we will (1)
determine the time course of neural activation during phonological working memory across the cortex, (2)
determine whether the same perceptual systems that represent phonological information during encoding also
actively maintain those representations during working memory, and (3) determine whether perceptual speech
systems participate in broader network-level dynamics during working memory maintenance. By achieving
these aims, this project will advance our understanding of the role perceptual speech systems play during
phonological working memory. Ultimately, such findings can be used to inform the theoretical basis for the role
of phonological working memory in language development and has implications for the clinical characterization
and remediation of phonological working memory deficits.

Public health relevance
PROJECT NARRATIVE Phonological working memory is the capacity to maintain and manipulate mental representations of speech sounds over short periods of time, and is believed to play a critical role in language development, supporting aspects of vocabulary learning, sentence processing, and acquisition of literacy skills. Even though the same areas of the brain that support speech perception have been found to be active during phonological working memory, it is unclear whether these regions participate in its functioning beyond the initial encoding of speech, thus complicating our ability to interpret observed correlations between low phonological working memory capacity and developmental language disorders. This project will use electrocorticography to investigate the neural dynamics of phonological working memory within speech cortex and across brain networks, in order to better understand the relationship between phonological working memory and language.